Excitation and inhibition in visual processing

Project Summary
A fundamental goal of systems neuroscience is to describe how sensory inputs are integrated and
guide an animal's behavior. To be able to integrate these inputs, early sensory systems have
developed selectivities for specific stimulus features that allow them to analyze the inputs using these
features as basis. A classic example is the emergence of orientation selectivity within the visual
cortex (Hubel and Wiesel, 1962). Successive processing stages in the early visual system perform
systematic transformations on the incoming inputs that enable them to be able to identify multiple
aspects of the visual scene important for guiding an animal's behavior, including the location, shape,
depth and motion of objects. While the unique feature selectivities emerging at different stages in
visual processing are known to a certain extent, the nature and mechanisms of these sensory
transformations less well-understood. We aim to uncover how disparate motion signals are
integrated to produce a global percept of motion, and to understand the conditions in which such
integration fails.

Public health relevance
Project Narrative A critical function of sensory processing is to integrate distinct information in order to generate a global representation that may be used to guide our behavior. For example, inferring the motion of complex objects requires the integration of multiple motion signals, each signal providing a constraint on the object motion. We will examine the neural circuitry that performs this computation using a combination of electrophysiology, imaging and behavioral experiments.